FETAL, NEONATAL AND CHILDHOOD EFFECTS OF IN UTERO EXPOSURE TO PCBS AND DDE

The long-term effects of in utero exposure to organochlorine compounds is of great potential importance. These compounds, which are detectable in nearly 100% of humans worldwide, have been linked to reduced neurodevelopment in children. In addition, p,p-DDE, the primary metabolite of DDT, is a weak estrogen, and an androgen receptor blocker at concentrations observed in humans.One objective of this project is to determine whether maternal serum concentration of DDE, obtained during pregnancy, is a risk factor for cryptorchidism, hypospadias and polythelia in male offspring. These malformations were chosen because they are markers of deficient androgen activity in utero. Other objectives are to determine whether in utero exposure to DDE is subsequently associated with an altered age at menarche in adolescent females and an increased risk of obesity in adolescent males, and whether in utero exposure to PCBs is associated with suboptimal muscle tone, reflexes, IQ and hearing during childhood.Work to date has demonstrated that these compounds can be recovered from the study population at relevant concentrations, and that the correlation between concentrations of these compounds in first and third trimester serum is sufficiently high to employ third-trimester serum as a surrogate for first-trimester exposure. Analysis of the concentrations of DDE and PCBs in serum for the main study will be complete, and analysis if the data will begin, early in FY 00. Serum analysis for the adolescent outcomes will begin in FY 00. - Organochlorine, polychlorinated biphenyls, DDE, biomarkers, pregnancy complications, congenital malformations, child development - Human Subjects: Interview, Questionaires, or Surveys Only